Maximizing the reach of universal child sexual abuse prevention: An equivalence trial

Child sexual abuse (CSA) is a public health problem affecting 1 in 5 girls and 1 in 12 boys before age 18.
National estimates indicate children ages 7 to 13 are at highest risk for CSA and CSA is associated with
lifelong negative sequelae. School-based prevention programs offer cost-effective universal programming
teaching students personal safety skills, knowledge to identify boundary violations and unwanted forms of
touch or contact, how to refuse approaches or invitations effectively, increase agency and access to resources.
Several programs have demonstrated effectiveness in increasing children’s knowledge of self-protection and
some have been linked with facilitating disclosures, including Safe Touches. Effectiveness notwithstanding,
the programmatic reach of universal school-based programs is limited by the inherent reliance on school
infrastructure and a dearth of available alternative delivery modalities, such as virtual delivery. This was most
recently highlighted by the unprecedented school closures to mitigate the spread of COVID-19 wherein the
infrastructure for prevention programming, and therefore the potential for school staff to identify potential abuse
and disclosures, was eliminated. These circumstances, though unusual, highlighted the need for flexibility in
the mode of delivery for effective school based preventive education programs even outside of pandemic
times. Though some evidence-based school-based programs may have transitioned to virtual delivery, none
have been empirically evaluated nor were they empirically compared against in-person versions. The proposed
R21 is designed to address this gap in the CSA prevention research field, uniquely leveraging an existing
partnership between university-based researchers (NYU), the Safe Touches model developer (NYSPCC), and
community-based organizations with active implementations of Safe Touches in two states representing
urban/rural, low/high income, and racially diverse settings. The study will use a rigorous cluster randomized
design to determine the equivalence of effectiveness between two delivery modalities of Safe Touches: in-
person vs. virtual. We will determine the equivalence of concept learning acquisition (Aim 1) and retention (Aim
2) among students in classrooms (N=180) that receive the in-person (n = 90) or virtual (n=90) Safe Touches
workshop. To conclude equivalence, it is important to examine factors that may impact future dissemination
and implementation, specifically program adoption among school personnel and implementation fidelity (Aim
3). Study findings will inform the ongoing development of effective CSA prevention programs and policy
decisions regarding the sustainable integration of such programs within school systems. Given the scope and
burden of CSA, especially among elementary aged students, it is a public health priority to efficiently
disseminate effective school-based prevention programs on a wide scale.

Public health relevance
PUBLIC HEALTH RELEVANCE Equipping elementary-age children with the tools to recognize unsafe touches and seek help from trusted adults is a critical step in primary prevention of child sexual abuse (CSA), but programs are limited in reach due to inflexible delivery modality. Safe Touches, is an evidence-based, universal CSA prevention program delivered to students in K-3 classrooms either virtually or in-person. Examining the equivalent effectiveness of Safe Touches workshop modality will increase the scalability and reach of Safe Touches, thereby maximizing the potential for public health impact.